Administrative Core

As described in the Overall component of this proposal, the overarching goal of the proposed Center is to
understand and address the molecular and genetic mechanisms underlying the FMR1 premutation
disorders, focusing on Fragile X tremor ataxia syndrome (FXTAS) and Fragile X associated primary
ovarian insufficiency (FXPOI), and to answer fundamental questions regarding the roles of the CGG
repeats in FMR1 function and dysfunction. The proposed Center integrates the substantial talents of research
groups at Baylor College of Medicine (BCM), University of Michigan School of Medicine (UM) and Emory
University School of Medicine (Emory). These groups have a significant history of collaborative interaction, and
their common interests will lead to robust findings that will suggest therapeutic approaches to FXTAS, FXPOI
and possibly fragile X syndrome (FXS). A well-defined leadership and management plan overseeing all research
endeavors is critical for the success of the proposed work and will ensure that goals set by the Center
Investigators are met in a timely and efficient manner. To accomplish the goals of our Center, the Administrative
Core will support the Center's Investigators. Led by co-Directors Drs. David Nelson and Peter Todd (leaders of
Projects 2 and 1, respectively), and assisted by Ms. LaTonya Beavers, the Administrative Core will be
responsible for the management and administration of the overall Center. The planning and coordination of the
synergistic research activities will be integrated through this central hub. Efforts will be conducted by an
Executive Team, including Drs. Emily Allen and Stephanie Sherman, Project 3 Co-PIs, with the guidance of an
Executive Advisory Board, composed of four external committee members who will address all Center operations
and help to ensure the timely completion of each proposed project. In addition, the Administrative Core will be
responsible for fiscal and resource management, as well as maintaining open lines of communication between
Center Investigators, Project Staff, NIH officials, and FX researchers. A significant emphasis will also be placed
on communication and engagement with the broader community of scientists and clinicians in neuroscience,
genetics, neurology, obstetrics and pediatrics, and with the public. Training and educational opportunities are
provided through regularly scheduled journal clubs, research presentations, and an annual Fragile X-Associated
Disorders (FXaDs) Symposium beginning in year 2. These activities will foster a deeper interest in FX research
in the new generation of young scientists, as well as encourage and stimulate investigators at all levels who may
not be in our field to pursue studies related to FXaDs. We envision that the BCM-Michigan-Emory Fragile
Research X Center will be a nexus of exciting scientific research, training and preclinical endeavors focused on
development of novel therapeutics for FXaDs.